Nutrient regulation of the EEC-vagal network

Project Summary
The increased high-sugar and high-fat diet consumption directly contributes to the
prevalence of obesity and metabolic disorders. The enteroendocrine cells (EECs) are
critical chemosensory cells in the intestinal epithelium. Following food ingestion, the
nutrients in the intestinal lumen are sensed by a subset of EECs. Recent research
demonstrated that the EECs that express Cholecystokinin (CCK) possess basal
membrane processes called neuropod to form synaptic connections with the vagal
sensory nerve fiber. Through the CCK+EECs-vagal synaptic connection, the nutrient
information in the intestinal lumen can be sensed and transmitted to the brain. The
CCK+EEC-vagal circuitry plays important roles in regulating food preference and feeding
behavior. However, the molecular mechanisms and the environmental factors that
regulate the EEC-vagal synaptic connections remain entirely unknown. Moreover, our
general understanding of the signaling molecules that drive the vagal innervation in the
intestine and the mechanisms that regulate the intestinal vagal network remains
extremely limited. As a result, our ability to manipulate intestinal vagal signaling and target
gut-brain nutrient sensing to treat diseases associated with feeding dysfunction and
metabolic disorders is handicapped. The proposed study will use novel genetic tools in
zebrafish models and in vivo imaging to directly visualize the dynamic EEC-vagal synaptic
communication in live animals. Our preliminary data demonstrate that EECs are important
for remodeling the intestinal vagal network and CCK+EECs express Brain-derived
neurotrophic factor (Bdnf). This proposal will test the central hypothesis that feeding and
nutrients dynamically regulate CCK+EECs Bdnf signaling to remodel CCK+EEC-vagal
synaptic connections and the intestinal vagal network. The first aim will use genetic tools
and CRISPR screening to determine the environmental factors and molecular
mechanisms that regulate Bdnf expression in CCK+EECs. The second aim will use a
novel genetic approach to directly visualize in vivo EEC-vagal synaptic connections to
determine the role of Bdnf signaling in CCK+EECs in regulating the EEC-vagal synaptic
connections and the intestinal vagal network. Accomplishing this proposal is expected to
reveal the first molecular mechanism and cellular signaling that drive the formation of the
EEC-vagal synaptic connection. It will reveal novel mechanisms that modulate the
intestinal vagal network, enhance EEC-vagal signaling transmission, and promote gut-
brain nutrient sensing. Selectively manipulating the EEC Bdnf signaling will offer new
opportunities to treat diseases that are associated with vagal disorders and gut-brain
nutrient sensing dysfunction.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it will reveal the first molecular mechanism and cellular signaling that is important for the formation of a gut-brain neuronal circuitry that is critical for regulating nutrient sensing and food preference. The proposed research is, therefore, relevant to the part of NIH’s mission that pertains to developing fundamental new knowledge that will enhance health and reduce the burdens of illness.